Brain aging and cognitive impairment in persons with HIV

PROJECT SUMMARY/ABSTRACT
While combination antiretroviral therapy has improved life expectancy for persons with HIV (PWH), cognitive
impairment persists in at least 30% of this population. However, it remains unclear whether brain aging is
accelerated, i.e. whether PWH have neurophenotypes resembling older uninfected (HIV-) controls. It is also
unclear how structural and functional brain aging relate to cognitive decline or preservation in PWH.
To enable the applicant to address these questions, this revised proposal includes a training plan focused
on further education in HIV clinical problems and practices, infectious disease biology, data analytics, and
scientific professional development. This plan includes mentored learning, clinical shadowing, didactic
coursework, and continuous engagement with an experienced, multi-disciplinary mentorship team. The
applicant’s long-term goals are to better characterize structure-function relationships in brain aging and
neurological infectious disease as an independent investigator performing clinically relevant neuroimaging.
In the Research Strategy, a multimodal MRI approach is proposed, incorporating both brain structure and
function. This approach will focus on two key neural biomarkers: white matter health and network connectivity.
White matter integrity will be measured with diffusion-weighted MRI (DW-MRI) from a large group of de-identified
PWH (n=440) and HIV- controls (n=255). Brain connectivity will be profiled using resting-state functional MRI
(rs-fMRI). DW-MRI and rs-fMRI will be used to generate brain-predicted age, a summary metric representing
systemic degeneration or dysfunction. Brain-predicted age will be calculated using machine learning regression
models, trained to predict participant ages from MRI. Brain-age gap (BAG), the difference between predicted
and chronological age, will be obtained for all participants.
The central hypothesis is that brain aging, including loss of structural integrity and network connectivity,
is accelerated in PWH, represented by elevated BAG among older PWH vs. HIV- controls. Aim 1 will test whether
age-like white matter degeneration is increased in PWH, while Aim 2 will investigate whether network functional
connectivity is decreased. As this population is at elevated risk for both clinical co-morbidities such as
cardiovascular disease and likely to experience socioeconomic disadvantages, it is critical to quantify the
contribution of such factors to brain aging. Aging with HIV is heterogenous, and many individuals present with
typical or even resilient cognition, so factors predicting successful brain aging should also be identified, especially
modifiable factors. Exploratory Aim 3 will model variability in brain aging among PWH as a function of clinical
variables, demographic and socioeconomic factors, and neuropsychological performance.
This research plan will provide insights into the origins of HIV-associated neurocognitive impairment, a
major clinical problem that reduces quality-of-life for millions of PWH. Together with the proposed training goals,
it will enable the applicant to obtain skills and knowledge vital for an independent neuroimaging research career.

Public health relevance
PROJECT NARRATIVE HIV infects the brain, and can diminish cerebral health and cognitive function despite the availability of drugs effectively targeting viral replication. This fellowship will investigate whether HIV produces patterns of structural damage and dysfunction similar to increased aging by using machine learning to estimate brain-predicted age from magnetic resonance imaging. This approach will help us understand the origins of cognitive impairment in persons with HIV, and may enable better prognosis and clinical care for those at risk of cognitive decline.